Investigation of capsule interactions that promote antimicrobial peptide activity

Project Summary.
The extracellular polysaccharide capsule of Klebsiella pneumoniae resists penetration by antimicrobials and
protects the bacteria from the innate immune system. While capsule inhibits most host defense peptides and
polymyxin antibiotics, a few amphipathic antimicrobial peptides have been identified that retain activity against
capsulated K. pneumoniae. However, it is not known what enables some peptides to avoid sequestration by K.
pneumoniae capsule while it effectively neutralizes most others. We have uncovered a mechanism that allows
synthetic antimicrobial peptides to overcome capsule inhibition. Specific amino acid changes in inactive
sequences enable peptides to bind, aggregate, and disrupt capsule layers, leaving K. peumoniae vulnerable to
their membrane attack. Through this proposal we will 1) explore this new mechanism in innate immune host
defense peptides that kill capsulated K. pneumoniae, and 2) characterize amino acid sequence and positional
variations that promote activity towards capsulated bacteria. Our results will provide important insight into
immune evasion by K. pneumoniae and other capsulated bacteria, and identify mechanistic principles will aid
the development new therapeutic approaches to overcome the capsule barrier.

Public health relevance
Project Narrative. Multi-drug resistant Klebsiella pneumoniae infections have become increasingly fatal in recent years. A defining feature of K. pneumoniae is its robust extracellular polysaccharide capsule that provides a protective barrier shielding it from immune recognition and host defense peptides. Through this proposal we will investigate the physical interactions of host defense antimicrobial peptides with capsule that differentiate active and inactive sequences, and characterize the amino acid composition that supports peptide activity.